Reversing age-related epigenetic changes and characterizing microglia heterogeneity in obesity and aging

Project Summary
Neuroinflammation is a hallmark of brain aging that may contribute to declines in function and neurodegenerative
diseases. As the resident macrophage of the brain, microglial are crucial to brain maintenance but have been
demonstrated to take on pro-inflammatory phenotypes with aging. The proposed research will examine the role
of microglia-specific epigenetic mechanisms in aging and determine the effects of obesity and aging interactions
on microglia phenotypic heterogeneity. We will determine whether aberrant age-related microglia-specific
epigenetic patterns can be reversed by heterochronic plasma approaches. Additionally, we will determine how
microglia subpopulations differ with age and obesity at a single-cell level with special interests in lipid-droplet-
accumulating microglia (LDAM). The goals of the training are to: 1) obtain a strong knowledge and foundation
in animal and nutritional models of anti-aging and obesity 2) gain hands-on experience in technologies and
bioinformatic skills needed for various omics approaches in specific hippocampal cells and at a single-cell level
3) apply these skills to achieve the research aims outlined in this proposal and 5) gain experience and improve
oral and presentation skills, manuscript and grant writing to enable a transition to independence. In Aim 1, we
hypothesize that exposure of old mice to young plasma will reverse age-related microglia-specific DNA
modifications to restore ‘youthful’ epigenomic patterns. This is based on the premise that DNA modifications are
key regulators of the diverse phenotypes required for the fulfillment of microglia functions which are disrupted in
aging. We will determine whether the administration of plasma from young into old mice can reverse age-related
microglial-specific hippocampal epigenetic and transcriptomic changes in Cx3cr1:NuTRAP mice using whole
genome oxidative bisulfite sequencing (WGoxBS) and RNA sequencing, respectively. These studies will identify
specific genomic sites amenable to the rejuvenating interventions and serve as targets for future epigenome
editing studies. In Aim 2, we will determine how the interaction of obesity and aging affect microglia
heterogeneity. We hypothesize that high-fat diet leads to expansion of pathological LDAM resulting in impaired
microglial function, which can be reversed by late-life calorie restriction. We will use single-cell transcriptomic
analysis, bulk transcriptomics and microglia functional assays (phagocytic uptake and cytokine/chemokine
analysis) to determine changes in microglia subpopulations in dietary-induced obese mice with age. In addition,
we will determine whether starting calorie restriction at 12 months in dietary-induced obese mice can mitigate
the effects of obesity on microglia heterogeneity. This will help identify mechanistic insights into microglia
heterogeneity, LDAM and obesity-associated neuroinflammation. In total, the training goals and objectives will
provide the needed skills and expertise to pursue a research career focused on developing anti-aging
interventions.

Public health relevance
Project Narrative In this project, we will determine whether plasma transfer approaches can reverse age-related epigenomic changes in microglia and identify genomic sites that could be targeted for mechanistic functional studies. We will also use single-cell molecular phenotypes, cell-specific translatomes, and microglia functional assays to characterize the dynamics of microglia populations in obesity and provide insights into aging- and obesity- associated neuroinflammation. Our long-term goal is to contribute mechanistic insights and knowledge into microglia aging and neuroinflammation and to develop novel strategies to promote healthy brain aging.